Ethanol & Anxiety: Cellular Mechanisms

The goal of the current application is to understand the relationship between alcohol exposure, withdrawal from chronic alcohol exposure, and the neurobiological mechanisms regulating anxiety-like behavior. The proposed experiments will utilize a rat model of chronic ethanol exposure and will integrate electrophysiological, cellular and molecular biological, and behavioral experimental approaches to examine the role of a specific brain region, the lateral/basolateral amygdala (BLA), in these processes. This brain area has been extensively implicated as an important regulatory component of the neural circuitry controlling anxiety-like behavior. Furthermore, findings from the previous funding period have shown extensive neurophysiological adaptations in both the glutamatergic and GABAergic neurotransmitter systems in the BLA. The objectives of the current proposal are therefore to 1) understand the neurobiological and cellular mechanisms governing these alterations and 2) define the role of BLA neurotransmitter systems in regulating anxiety-like behavior associated with chronic ethanol exposure and subsequent withdrawal. Our proposed experiments will specifically test the central hypothesis that anxiety during withdrawal from chronic ethanol exposure is caused by functional alterations within the major amygdala neurotransmitter systems. Specific Aim 1 will test this hypothesis by characterizing neurophysiological and molecular alterations in glutamate neurotransmission following a chronic intermittent ethanol inhalation exposure in rats. Experimental approaches include in vitro slice patch-clamp electrophysiology to examine the function of BLA glutamatergic afferents and biochemical analysis of glutamate receptor expression and localization. Specific Aim 2 will examine chronic ethanol- and withdrawal-related alterations in rat BLA GABAergic neurotransmission and receptor expression. In vitro slice whole-cell electrophysiology will be used in this aim as well. In addition, real-time RT-PCR will be employed to analyze molecular adaptations in the BLA GABAergic system. Specific Aim 3 will address our central hypothesis by directly examining BLA glutamatergic and GABAergic alterations in the context of enhanced expression of anxiety-like behavior following chronic ethanol exposure. The proposed experiments will specifically examine the evolving relationship between exposure and withdrawal time course and neurophysiological function. Additionally, traditional behavioral pharmacological approaches will be used to better understand how changes in this neurobiological function contribute to the expression of withdrawalrelated anxiety. Ultimately, the proposed experiments will better define the specific neurobiological contributions of the amygdala to anxiety-like behavior expressed following chronic alcohol exposure and withdrawal. These studies could therefore provide insight into the cellular mechanisms governing anxietyassociated relapse in human alcoholics.